Molecular Mechanisms of Retroviral Gag-RNA interactions in Virus Assembly

Abstract
Retroviruses are positive-sense, single-stranded RNA viruses that cause cancers and severe
immunodeficiency diseases in animals and humans, including human immunodeficiency virus. For over a
century, Rous sarcoma virus (RSV), which causes cancer in domestic fowl, has served as a powerful model
system to dissect the molecular basis of retroviral replication, including retrovirus assembly. Gag, the major
structural protein of retroviruses, orchestrates the assembly of virus particles that bud from the plasma
membrane of infected cells. To initiate particle assembly, Gag selectively binds unspliced viral RNA as the
source of genomic RNA in virions. This proposal focuses on the mechanism by which Gag selects genomic
RNA, addressing fundamental, unanswered questions in the field: (i) where in the cell does the initial contact
between Gag and viral RNA occur; (ii) how does Gag selectively recruit unspliced viral RNA for packaging
when it comprises only ~1% of the total RNA in an infected cell; and (iii) what are the properties of Gag-viral
RNA complexes that promote transport through the cell to the plasma membrane for particle release? Because
virus particles bud from the plasma membrane, it was originally thought that initial Gag-genomic RNA
interactions occurred in the cytoplasm. Our laboratory discovered that RSV Gag undergoes nuclear trafficking,
which is required for efficient genomic viral RNA packaging. This finding raised the possibility that Gag binds
genomic RNA in the nucleus, which challenges the dogma for how retroviruses package their genomes.
Our imaging and biophysical studies have revealed that the RSV Gag protein forms discrete nuclear,
cytoplasmic, and plasma membrane foci that have properties of biological condensates, which have recently
been shown to be important in regulating cell biology processes and virus-host interactions. We have observed
that the Gag nuclear foci colocalize with unspliced viral RNA, suggesting that RSV Gag initially binds genomic
RNA in the nucleus. In Aim 1, we will determine whether RSV Gag binds genomic RNAs at transcription sites
using super-resolution live cell imaging, deep sequencing, single molecule fluorescence imaging, and
CRISPR-based approaches. In Aim 2, we will use biophysical approaches to examine whether Gag-genomic
RNA complexes form biological condensates that adopt properties of membrane-less organelles and undergo
liquid-liquid phase separation. We will test the hypothesis that Gag-genomic RNA condensates remain tightly
packed as they cross the nuclear envelope and traffic through the cytoplasm to the plasma membrane, where
virus particles are assembled. Together, these experiments will move the field forward with new insights into
how retroviruses select their RNA genomes and transport them to the plasma membrane for budding.

Public health relevance
Project Narrative Retroviruses are positive-sense RNA viruses that cause cancer and severe immunodeficiency diseases in humans and animals. To spread infection, retroviral RNA is encapsidated into new virus particles released from the cell through budding from the cell membrane. This research project uses advanced microscopic imaging and biophysical methods to dissect the mechanisms of retrovirus assembly with the goal of identifying new strategies to disrupt the production of new virus particles.